A self-organizing embryoid model of peri-implantation human development

Project Summary
The amniotic membrane forms a tough fluid-filled sac that protects the developing embryo and is essential for
a successful pregnancy. Amniogenesis initiates early in human development as the embryo implants into the
uterine wall: the inner cell mass first polarizes to form a pluripotent cyst with central lumen and subsequently,
one half of this polarized cyst loses pluripotency markers and becomes squamous in nature (the prospective
amniotic ecotderm) while the other side (the epiblast) remains pluripotent. Gastrulation begins on the epiblast
side soon thereafter. These early post-implantation developmental steps are inaccessible to study in humans,
leaving an enormous gap in our knowledge about amnion fate determination and formation of the amniotic sac,
despite the central importance of these events to the survival of the developing embryo. A new in vitro model
can help to close that gap: human pluripotent stem cells (hPSC), cultured in specific 3D conditions, form
polarized pluripotent cysts that spontaneously self-organize into symmetric cysts composed entirely of amnion
cells (90-95%) as well as asymmetric cysts that resemble amniotic sac-like structures (5-10%). Asymmetrically
patterned cysts mirror Carnegie stage 5c human embryos and are called “post-implantation amniotic sac
embryoids” or “PASE”. Cyst formation occurs progressively over five days in culture. Live imaging shows that
asymmetric cysts arise from focal flattening at one pole of the cyst and laterally spreading of amnion fate;
symmetric cysts arise when flattening occurs in a multi-focal pattern. Mechanistically, the initial trigger for
amnion differentiation is mechanical and that this causes presumptive amnion cells to activate a BMP signaling
program that is both necessary and sufficient for amniogenesis. At 5 days of culture, PASE contain distinct
populations of amnion, epiblast and boundary cells; epiblast cells initiate EMT movements similar to
gastrulation. We will exploit this robust in vitro model to accomplish the following goals: Aim 1) Explore how
mechanical signals activate BMP signaling. Novel PiggyBac-based tools for genetic modification of hESC will
aid in these studies. Aim 2) Establish the hierarchy of gene activation that results in amniogenesis and
development of mature PASE. Single cell RNAseq will be used to dissect the transcriptional cascade that
accompanies symmetry breaking, spreading amniogenesis, boundary formation and initiation of epiblast EMT
movements. Aim 3) Functionally test transcription factors that control amnion fate. Genetic deletion and
overexpression studies will be used to explore the role of several potential master regulators of amnion fate.
Overall, the work proposed here will greatly accelerate the pace of discovery regarding critical but previously
inaccessible post-implantation events and thus will have enormous implications for understanding early
processes that impact embryonic development and human fertility.

Public health relevance
Relevance An in vitro model of hESC-based self-organization will be used to tackle previously unexplored events in human post-implantation development: formation of the amniotic epithelium and generation of the amniotic sac. The data will establish how a mechano-transduction event couples to a BMP-driven signaling cascade that induces amniotic epithelial fate and will expand the available model systems for the study of amniogenesis. The data will have major relevance for post-implantation development and human fertility, since no other current model cannot efficiently and molecularly dissect the underlying processes.